Cellular Models of PAH-Associated Molecular Defects as a Tool for Identifying New Therapeutic Targets

Sub-Project 1: Rare Genetic Defect in Glucose Metabolism as a Model for Investigating Mechanisms Underlying Vascular Remodeling in PAH

Glucose-6-phosphatase catalytic subunit 3 (G6PC3) is a ubiquitously expressed enzyme that maintains intracellular glucose homeostasis by catalyzing the hydrolysis of glucose-6-phosphate to glucose in the endoplasmic reticulum. Loss-of-function mutations in G6PC3 lead to an autosomal recessive, multi-system syndrome of severe congenital neutropenia with a broad phenotypic spectrum that includes a high incidence of congenital heart defects. A subset of affected patients exhibits Dursun syndrome, a triad of congenital neutropenia, atrial septal defect and PAH. While the effect of G6PC3 deficiency on neutrophil function has been thoroughly studied, little is known about its impact on the vasculature. We hypothesize that investigation of a rare but well-characterized genetic cause of disrupted cellular energy homeostasis will provide valuable insight into how metabolic reprogramming contributes to PAH pathobiology.

Aim 1: Determine the phenotypic consequences of G6PC3-silencing in human pulmonary artery and human pulmonary microvascular endothelial cells (ECs).

In FY23, based on the results of hemodynamic studies in G6pc3 knockout (KO) mice, we examined the effects of shear stress and glucose concentration on NOS3, END1, ACE2, ACTA2, and VWF gene expression in G6PC3-deficient primary human pulmonary artery ECs.

Aim 2: Investigate the impact of G6pc3 deficiency on pulmonary vascular function in vivo using KO mice under both normoxic and chronic hypoxic conditions. These murine studies were done under an ACUC approved Animal Study Proposal (CCM 20-03).

In FY23, G6pc3 KO mice and wild-type (WT) littermate controls were exposed to either normoxia or hypoxia for 5 weeks and then underwent cardiac catheterization. Compared to WT littermate control animals, male G6pc3 KO mice have significantly higher baseline right ventricular systolic pressure (RVSP) under normoxic conditions whereas female KO mice do not. Exposure to chronic hypoxia further increases RVSP in male KO mice compared to male WT controls.

Aim 3: Develop and characterize patient-specific in vitro models of endothelial dysfunction using induced pluripotent stem cell (iPSC)-derived endothelial cells.

In FY23, in collaboration with Dr. David McDermott, peripheral blood mononuclear cells were collected from two new subjects with loss-of-function mutations in G6PC3 (homozygous for c.246 G>A). These cells will be used to develop patient-specific iPSCs.

Sub-Project 2: Mechanisms Leading to Interferon Activation in Caveolin-1 (CAV1) deficient primary human pulmonary artery ECs

Recently, comprehensive in vitro characterization of CAV1 deficiency in human lung endothelium revealed a proliferative, interferon (IFN)-biased inflammatory phenotype driven by constitutively activated STAT and AKT signaling. PAH patients with CAV1 mutations also had elevated serum CXCL10 levels and their fibroblasts mirrored phenotypic and molecular features of CAV1-deficient PAECs. Moreover, immunofluorescence staining revealed endothelial CAV1 loss and STAT1 activation in the pulmonary arterioles of patients with idiopathic PAH, suggesting that this paradigm might not be limited to rare CAV1 mutations. Finally, inhibiting JAK/STAT and/or PI3K/AKT reversed this aberrant cell phenotype and may ameliorate vascular remodeling in PAH (Gairhe et al. PNAS 2021).

In FY23, we continued investigations into the mechanisms underlying STAT1 activation following CAV1 loss in human PAECs. In addition to constitutively activated STAT1, we also previously observed that NOS3 phosphorylation at serine 1177, a post-translational modification associated with NOS3 uncoupling and increased oxidant stress, is also increased in CAV1-deficient PAECs (Gairhe et, PNAS 2021). Consistent with this observation, we observed both increased reactive oxygen species (ROS) and evidence of nitrosative stress in CAV1-silenced PAECs. Importantly, co-silencing NOS3 in CAV1-deficient cells not only attenuated STAT1 phosphorylation and ROS production but also reversed the proliferative phenotype. Thus, NOS3 dysfunction appears linked to STAT1 activation and the abnormal phenotype of CAV1-silenced PAECs. Importantly, both PKA and AKT can phosphorylate NOS3 at serine 1177 and therefore represent possible signaling mediators in the context of CAV1 deficiency. Increased phosphorylation of nuclear CREB, a known target of PKA and AKT, further implicated a role for either or both of these kinases in shaping the phenotype of CAV1 deficient PAECs. Interestingly, while PKA inhibition blocked phosphorylation of STAT1 and NOS3 in CAV1-deficient PAECs, inhibiting transmembrane adenylyl cyclase (AC), a major regulator of PKA, did not. In addition to transmembrane AC, a soluble isoform of AC also exists and its activation is associated with impaired endothelial function. Using two different small molecule inhibitors, we demonstrated that blocking soluble adenylyl cyclase (AC10) attenuated ROS production, STAT1 and NOS3 phosphorylation and cell proliferation in CAV1-silenced PAECs. We plan to further investigate the role of soluble adenylyl cyclase and PKA in STAT1 activation with the goal of identifying therapeutic targets that can ameliorate the inflammatory remodeling in PAH.

Sub-Project 3: Efficacy of PI3K/AKT Pathway Inhibition on Pulmonary Vascular Remodeling in Rat Models of Pulmonary Arterial Hypertension

Activation of the PI3K/AKT pathway is a prominent, shared feature across our models of PAH-associated molecular defects. Leniolisib is a PI3K-delta inhibitor that has been very well tolerated in children with activated PI3K-delta syndrome and reversed the hyperproliferative, apoptosis-resistant cellular phenotype in our in vitro PAH cellular models. In collaboration with Novaris/Pharming, we first tested RB-50-LV29 (abbreviated RB), a tool compound for leniolisib, in our rat SU5416-hypoxia PAH model. More recently we have obtained leniolisib for additional in vivo studies. These animal studies are conducted under ACUC approved Animal Study Proposals (CCM 19-03, CCM 19-07 and CCM 23-01).

In FY23, in vivo testing of RB was completed. Male and female Sprague-Dawley rats (N=54) were subcutaneously injected with SU5416 (20 mg/kg), exposed to hypoxia (10% FiO2) for 3 weeks and then returned to normoxia for 5 weeks (referred to as SuHx rats). SuHx rats were randomly assigned to receive either RB (n=14, 60 mg/kg/d; n=12, 120 mg/kg/d) or placebo (n=28) from weeks 5 to 8. Age-matched male and female normoxic controls were also randomly assigned to receive either RB (n=8, 60 mg/kg/d) or placebo (n=8) from weeks 5 to 8. Compared to placebo-treated SuHx rats, mean right ventricular (RV) systolic pressure was lower in SuHx rats that received high dose RB (120 mg/kg/d) but not low dose RB (60 mg/kg/d). Treatment with high dose, but not low dose RB also reduced the number of completely occluded pulmonary arterioles but did not reduce pulmonary arteriolar muscularization or RV hypertrophy in SuHx rats. Left heart catheterization revealed no significant difference in mean systemic blood pressure or left ventricular end diastolic pressure between normoxic controls and SuHx rats with or without RB treatment.